Genomic surveillance for artemisinin resistance in Africa: moving beyond a candidate gene approach

PROJECT SUMMARY
Artemisinin-based combination therapies (ACTs) are the first-line treatment for malaria in most endemic
countries. Emergence of resistance to the artemisinin derivatives and key partner drugs in Southeast Asia raised
fears that resistance could spread, or emerge independently, in sub-Saharan Africa, where the malaria burden
is greatest. Such fears are being realized with reports of artemisinin-resistant Plasmodium falciparum in areas
of East Africa, highlighting the need for proactive resistance surveillance. To date, surveillance for artemisinin
resistance has focused on estimates of parasite clearance following treatment with ACTs in the context of drug
efficacy studies or genotyping of mutations in the gene encoding Kelch13 (K13). Mutations in K13 are sufficient
to cause parasite resistance to artemisinins; however, multiple studies have indicated that artemisinin resistance
is multigenic, involving several altered biological processes, and is not always K13-mediated. Likewise,
estimates of delayed parasite clearance, the hallmark of artemisinin resistance in Southeast Asia, are
confounded by host immunity in high malaria transmission settings of Africa. In the proposed work, we aim to
evaluate a genomic surveillance approach that involves sampling of parasite populations over time following
ACT implementation to identify mutations under selection in functional pathways implicated in artemisinin
resistance. We hypothesize that alteration of specific biological functions, rather than mutation of specific genes,
is important for parasite resistance to artemisinins. We will first identify parasite loci under selection over time in
four endemic countries and perform analyses to identify enriched functions among genes under selection (Aim
1). Altered functional profiles associated with artemisinin resistance on different genetic backgrounds will be
validated using P. falciparum genetic crosses, and specific loci under selection in Mali will be validated for their
role in artemisinin resistance using transcriptomic analyses and forward-genetic screens (Aim 2). We will then
use amplicon sequencing to assess population-level and within-host dynamics of selected alleles in Mali to
estimate selection coefficients and parasite clearance rates to inform the design of temporal sampling and
prioritization strategies for future genomic surveillance studies (Aim 3). We anticipate that the proposed
selection-based approach will identify parasite adaptation to drug pressure earlier in the evolutionary timeline of
emerging resistance before it manifests clinically. Likewise, we expect that the reduced cost of sequencing and
increased bioinformatics capabilities in low-and-middle-income countries will make genomic surveillance a
tractable option for resistance surveillance.

Public health relevance
PUBLIC HEALTH RELEVANCE Plasmodium falciparum resistance to artemisinin derivatives has emerged in parts of sub-Saharan Africa, threatening the efficacy of first-line antimalarials in the highest malaria burden areas of the world. There is a critical need for early warning signals of emerging artemisinin resistance in Africa that are not dependent on clinical phenotypes confounded by immunity and that move beyond genotyping of single candidate genes that are not fully representative of the broad and multigenic mechanisms of artemisinin resistance. This research will provide proof-of-concept for a phenotype-independent genomic surveillance approach to detect selection in populations sampled over time in genes involved in parasite functions implicated in artemisinin resistance.